Partnership for Global Health Research Training Program(Renewal)

Project Summary/Abstract
The HBNU Fogarty Global Health Training Program (the HBNU Program) fosters the next generation of global health scientists by enhancing research capacity in resource-limited settings through a rigorous mentored research training plan for trainees early in their career. Specifically, the HBNU Program aims to support trainee research focused on reducing mortality and morbidity associated with: HIV/AIDS and associated co-infections; noncommunicable diseases (NCDs) including cardiovascular disease, diabetes, and cancer; psychological and emotional health; and maternal and child health and nutrition (MCHN). In addition to mentored research, training will include didactic components to develop competency in rigorous research design and methods, evaluation and analytic capacity, regulatory issues, and global collaboration. The Program brings together leading academic research institutions with longstanding relationships in a variety of disciplines and with multidisciplinary research capacities. The four U.S. academic research institutions that will anchor our consortium are: Harvard University (Harvard T. H. Chan School of Public Health); Boston University (School of Public Health); Northwestern University (Institute for Global Health, Feinberg School of Medicine); and the University of New Mexico (School of Medicine, Center for Global Health).
Our consortium’s partner research sites are 21 well-qualified institutions in 14 countries. These sites have strong pre-existing relationships with the Program’s principal investigators and institutions and have demonstrated capacity to provide outstanding mentored experiences. Specific Aims include: AIM 1: Recruit qualified U.S. predoctoral and U.S. and international postdoctoral applicants; including at least 17 trainees per year for Years 1-2 and 16 trainees per year for Years 3-5, for a minimum of 82 trainees over the award period; AIM 2: Deliver a comprehensive education and research support program, including Field Preparedness Training, Monthly Seminars, and U.S. based training for international trainees, that will combine in-person and online learning and access to collaboration tools to support trainee individual professional development and research project implementation; AIM 3: Provide trainees with rigorous mentored research experiences at international research sites with a very strong track record of peer-reviewed publications and NIH research outputs; AIM 4: Build global health research capacity at consortium member institutions and internationally through activities such as alumni mentors and the Mentor Symposium. Ultimately, the Program will prepare a future generation of leaders to tackle and solve the most challenging global health problems through early investment in committed predoctoral and postdoctoral trainees to foster scientific creativity at a transformative stage in their career.

Public health relevance
Project Narrative The HBNU Fogarty Global Health Training Program, a consortium of Harvard University, Boston University, Northwestern University and the University of New Mexico, proposes to continue to contribute to global health research capacity building and the use of research to improve health outcomes related to priority health areas in resource-limited settings in partnership with 21 sites throughout Africa, Asia, and South America. The Program will recruit trainees from the United States and international trainees to strengthen global health research networks and programs at academic institutions and ultimately help sustain global health research in the US and abroad. This Program strengthens America’s health and preparedness by expanding the nation’s capacity for world-class biomedical research and reinforcing critical global health partnerships. By training US and international scientists to tackle major health challenges such as infectious and chronic diseases, and maternal and child health, the Program ensures the United States remains at the forefront of preventing, detecting, and responding to health threats that can impact the American people. The findings, skills, and best practices generated will inform domestic research and public health policies, enhance the nation’s response capabilities, and ensure that federal investments yield maximum impact—advancing the mission of improving and protecting the health of Americans.